Failed Regeneration in the Muscular Dystrophies: Inflammation, Fibrosis and Fat

DESCRIPTION (provided by applicant): This MDCRC is organized around the concept that limiting fibrosis in the muscular dystrophies will help extend the period of successful regeneration via the patients' own satellite cell repair, increase the benefits associated with therapies that increase the patients' muscle repair capacity, and will extend the age at which patients can benefit from eventual viral gene or stem cell therapies. Thus the primary objectives of this MDCRC are to facilitate the attainment of clinically useful pharmacological means of inhibiting fibrosis and to identify the best existing pharmacological inhibitors of fibrosis, as well as drive the development of new classes of inhibitors. Our further goal is to develop non-invasive imaging techniques to assess the progression of fibro-fatty replacement of skeletal and cardiac muscles. In Project 1, Drs. Sweeney and Spencer (in collaboration with Drs. McNally, Barton, Miceli, Discher and Epstein) will follow the fate of satellite cells during the progression of disease in mdx and A/J mice, while characterizing changes in muscular tissue, fibrosis and fat. The project will go on to analyze inhibitors of inflammation and/or fibrosis and their impact on disease pathology in mdx and A/J mice. In Project 2, Dr. McNally will search for modifiers of cardiac fibrosis by examining mouse models of muscular dystrophy on different genetic backgrounds. Stan Nelson (UCLA) will collaborate on Project 2. In Project 3, Drs. Walter and Vandenborne will continue their project focused on the development of non-invasive monitoring of disease progression in muscular dystrophy. They will be aided and advised in this effort by Drs. Bonnemann, Finkel, McNally, Sweeney and Byrne. An Administrative Core (Core A) will support all projects, as well as provide the administrative support for our symposia and bi-annual international muscular dystrophy meeting, and to oversee the use of non-NIH funding for the Center. The Center will also have a major training and educational component, under the direction of Drs. Ostap and Finkel (Core B: Training and Education Core). A Physiological Assessment Core (Core C) will support Project 1 and continue as a national source for evaluating therapeutic inten/entions in mouse models of Muscular Dystrophy.